Acquisition of a Self-Balancing Powered Exoskeleton for Mobility and Physical Rehabilitation

PROJECT SUMMARY/ABSTRACT
There is a strong need at NJIT and its research and clinical collaborators to develop a deeper understanding of
human-robot interaction during exoskeletal-assisted locomotion (EAL). To address this need, the proposal
requests funding to acquire a self-balancing, hands-free lower extremity exoskeleton and test the efficacy of this
device to promote functional independence in people with neurological disorders. The long-term goal of this
work is to enable robotic exoskeletons to integrate seamlessly for in-home and community use, restoring mobility
and quality of life of individuals with neurological disorders on par with their able-bodied peers.
Although robotic exoskeletons have tremendous potential, current devices fall short of safely restoring
mobility in individuals with neurological disorders. This is in large part because robotic exoskeletons for
rehabilitation are relatively new, with commercial devices receiving Food and Drug Administration (FDA)
approvals in the past seven years (ReWalk in 2014, Indego and Ekso in 2016). The growing demand for robotic
exoskeletons has exposed two critical barriers to safe and sustained use: 1) the bounds of human-robot
performance during EAL are not well-understood because empirical data under controlled laboratory settings
do not exist or are not available to the research community; and 2) it is difficult and prohibitively expensive to
conduct the necessary experiments to characterize systematically human-robot performance during EAL. In
addition, all three FDA-approved devices currently used in the United States require hand-held crutches or a
walker. This excludes a subset of population with neurological disorders who do not have adequate control or
strength in their arms. The crutches/walker also limit the intensity and range of activities a user can engage in
while in the robotic exoskeleton, limiting the utility of such assistive devices to regain functional independence
and quality of life.
The acquisition of the self-balancing, hands-free exoskeleton would greatly strengthen on-going research
funded by the NIH and other federal agencies. These interdisciplinary research projects span a large range,
including controlled experiments in laboratory settings to acquire fundamental knowledge about human-robot
interaction in exoskeletons, developing subject-specific virtual simulators of EAL, understanding the efficacy of
EAL to improve gait characteristics and functional independence in patient populations, and developing virtual
reality platforms for training vulnerable populations in exoskeleton use. Collectively, these projects will provide
the much-needed empirical data and technology developments to accelerate integration of robotic exoskeletons
for in-home and community use.

Public health relevance
PROJECT NARRATIVE Although robotic exoskeletons have tremendous potential to restore mobility and quality of life, current FDA- approved devices require crutches or a walker, thus excluding patients with affected or weak upper bodies from participating. To include these patients in exoskeletal-assisted rehabilitation, we propose to acquire a self- balancing, hands-free exoskeleton and test the efficacy of this device to promote functional independence and quality of life in people with neurological disorders. We will perform a broad range of experiments with able- bodied and different patient populations, and build virtual simulators to characterize human-robot interaction during exoskeletal-assisted locomotion.